2024 Metals in Medicine Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
The Metals in Medicine Gordon Research Conference and the inaugural Gordon Research Seminar (MiM
GRC/GRS) bring together leading academic and industrial researchers from around the world. The GRS is
chaired by two senior postdoctoral fellows and provides a forum for trainees to present talks and exchange ideas.
These companion conferences will explore the role metal ions, their complexes, and metal-binding
macromolecules play in the scope of human health. The objectives of the 2024 MiM GRC, “Fostering
Connections from Inorganic Chemistry to Diagnosing and Treating Disease” and the 2024 MiM GRS “The Future
of Metals in Medicine: Empowering Young Scientists through Connection” are reflected in the following specific
aims:
Aim 1) Advance research on metal complexes, metal-containing bioconjugates, and metal-complexed
macromolecules to develop novel, transformative, agents for use in the diagnosis, imaging, and treatment of
disease. Presentations range from basic science to clinical-translation of metal-based agents for diagnosis and
therapy. Sessions will include “Radiation Protection”, “Metal-based Therapeutics for Infectious Diseases”, “Drug
Delivery and Targeted Therapies” and “Clinical Advances”.
Aim 2) Present the latest findings on the role that metals play in mechanisms of both the pathological basis for
disease and how to incorporate this in designing new medical treatments. Presentations will focus on the role of
metals in disease and treatments. Sessions on basic science include “Stimuli-responsive Metallodrugs as
Emerging Therapeutics” and “Advances in Metallomics”. Speakers in the session “Unconventional Metal-based
Therapeutics” will discuss unique metallodrugs targeting diseases through cytoprotective means and those that
battle chemoresistance.
Aim 3) Provide a stimulating and dynamic gathering to engage and inspire early career scientists of diverse
backgrounds. The session “Addressing Health Disparities and Increasing Diversity and Inclusion in Biomedical
Research” will highlight advances in the study of biological determinants in health disparities, and the use of
improved disease models. Strategies to increase recruitment, inclusion and retention of researchers of
underrepresented backgrounds (specific racial ethnic backgrounds, LGBTQIA+ groups, disadvantaged
individuals, individuals, with disabilities) will also be discussed. “Poster Previews” feature postdoctoral fellows
and graduate students giving brief oral presentations on “Why you should visit my poster”. The “Power Hour” will
address issues around career advancement for STEM women scientists and other underrepresented groups.
The GRS will have a panel discussion on mental health in academia. The combination of formal and informal
activities and interactions offer support and mentoring for the professional growth of the meeting participants.

Public health relevance
PROJECT NARRATIVE The proposed conference is relevant to public health, since it will help advance metallodrug and metal-based radiopharmaceutical research for the development of more effective therapies and with fewer clinical problems than drugs currently used for the treatment of cancer, and infectious diseases. Thus, the findings are ultimately expected to be applicable to the health of human beings.